Peer Behavioral Activation Utilization to Improve Substance Use and HIV Outcomes in People Receiving Long Acting Injectable-PrEP/ART (PUSH).”

Background. Substance use continues to be a major driver of HIV acquisition and has been associated with suboptimal ART adherence, treatment interruption, and inability to achieve or maintain viral suppression. Though PrEP is a key tool for HIV prevention, awareness, uptake, and adherence are disproportionately lower among people who use drugs. New long-acting injectable (LAI) formulations of PrEP/ART provide a potential biomedical intervention to overcome adherence challenges, however, due to the prolonged subtherapeutic period after LAI discontinuation, ensuring adherence is crucial. A peer-delivered reinforcement-based intervention may be a promising solution for improving LAI adherence. Our team has developed, through several rounds of stakeholder feedback, a peer-delivered behavioral activation and problem-solving intervention, Peer Activate. Peer Activate focuses on problem-solving skills to improve adherence to ART and/or PrEP at multiple levels and includes behavioral activation to promote engagement in rewarding, substance-free activities in one’s environment and structured daily activities to promote treatment adherence. However, Peer Activate has not been evaluated in the context of LAI PrEP/ART.
Preliminary Studies. This proposal builds upon our team’s prior studies demonstrating 1) our ability to engage patients with and at risk for HIV and provide LAI PrEP/ART in community-based settings; 2) the feasibility and acceptability of Peer Activate and promise in improving HIV treatment adherence for people who use substances; and 3) promise for cost-effectiveness.
Approach. We propose a randomized Type 1 hybrid effectiveness-implementation trial (N=186) to test the effectiveness and implementation of Peer Activate for LAI PrEP/ART (“Peer Activate-LAI”) vs. enhanced treatment as usual for a substance using population living with or at high risk for HIV, evaluating the following over 12 months: (1) Effectiveness: a) LAI PrEP/ART adherence (primary; receipt of all 6 maintenance injections within 7-day window); b) substance use (secondary; urine toxicology, self-report); c) moderators of effectiveness (exploratory); (2) Implementation of Peer Activate-LAI including feasibility, acceptability, fidelity, and adoption guided by RE-AIM and Proctor’s model, assessed using mixed methods, including a rapid ethnographic assessment of how life course factors may affect implementation; and (3) Economic viability of Peer Activate- LAI, including cost of implementation and sustainment and cost-effectiveness from multiple stakeholder perspectives. Implications. This study will inform a potentially scalable, cost-effective model for facilitating effective adherence to LAI formulations of ART/PrEP within substance using populations who to date have had limited support for improving LAI adherence for HIV ART/PrEP.

Public health relevance
Individuals with substance use disorder (SUD) face worse HIV treatment and prevention outcomes. Although long acting injectable (LAI) formulations of HIV treatment and prevention are being developed, additional adherence support is still needed. Implementing an evidence-based, peer delivered approach to support adherence to LAI interventions may be a feasible, acceptable, and sustainable way to improve HIV treatment and prevention outcomes among individuals with SUD.